Investigating the metal-dependent function, allostery and inhibition of CRISPR-Cas9

Abstract
CRISPR-Cas9 is the core of a transformative genome editing technology that is innovating life
science with cutting-edge impact in basic and applied sciences. By enabling the correction of DNA
mutations, this technology promises to treat a myriad of human genetic diseases, as shown for the first
cancer patients treated with CRISPR-Cas9–modified T-cells. This technology is based on the
endonuclease Cas9, which associates with guide RNAs to recognize and cleave complementary DNA
sequences. Ceaseless development and engineering of CRISPR-Cas9 tools has opened novel
intriguing hypotheses that grant in-depth investigations of the system. Here, the PI will implement
unconventional multiscale approaches, combining a variety of state-of-the-art theoretical methods, to
clarify the metal-dependent catalysis, the allostery in the selectivity mechanisms, as well as the inhibition
of the system. We will pursue three specific aims, characterizing: (Aim 1) the DNA cleavage dependency
on alternative divalent metal ions other than Mg2+ and the conformational effects associated with their
binding; (Aim 2) the allosteric modulation witnessed in newly engineered Cas9 variants with enhanced
specificity; (Aim 3) the inhibition mechanism by naturally occurring anti-CRISPR proteins to implement
control over gene regulation. Toward these aims, we will leverage classical and enhanced sampling
molecular dynamics (MD) simulations, high-level ab-initio MD (using the Car-Parrinello and Born-
Oppenheimer approaches) and mixed quantum mechanics/molecular mechanics (QM/MM)
approaches. Moreover, combination of ab-initio MD with graph theory will implement a synergistic
approach capturing instantaneous sub-nanosecond signaling transfers. This will reveal how long-range
allosteric effects impact the dynamics through evolving catalytic steps, elucidating the role of allostery
in aiding catalysis. These multiscale approaches will offer a computational framework for the biophysical
analysis of not only CRISPR-Cas9, but can also be extended to emerging CRISPR systems that are
promising for genome editing and viral detection. Theoretical studies will be performed in close
collaboration with experimental scientists, providing kinetic measurements and biophysical
characterization, assisting in the interpretation of the experimental data and enabling testable
predictions. Overall, this proposed research will expand the repertoire of mechanistic knowledge
regarding the CRISPR-Cas9 function and lay the framework for novel engineering rationales toward
improved genome editing.

Public health relevance
Narrative Errors in the genome can often give rise to plethora of genetic diseases, including cancer and neurodegeneration and, in recent years, the CRISPR-Cas9 complex has emerged as promising genome editing machinery to treat a myriad of human genetic diseases as shown for the first cancer patients treated with CRISPR-Cas9–modified T-cells. This prosed research will leverage state-of-the-art computational methods to answer critical biophysical questions and foster improved applications of the CRISPR-Cas9 genome editing technology. Understanding the fundamental functional behaviour of this complex is of utmost importance to ameliorate safety and efficacy for clinical applications.